NCCAT: National Center for CryoEM Access and Training

Project Summary/Abstract
The National Center for CryoEM Access and Training (NCCAT) enables users to solve macromolecular
structures rapidly and to the highest possible resolution using cryo-electron microscopy (cryoEM) methods. We
propose to continue to: (1) Provide access to state-of-the-art equipment, (2) Maintain a highly qualified
technical team offering direct support, guidance, and assistance, (3) Operate a comprehensive cross-training
program for users across diverse skill levels and career goals, and (4) Ensure equal opportunity nationwide
access through an open and transparent application process. NCCAT is housed at the Simons Electron
Microscopy Center (SEMC) within the New York Structural Biology Center (NYSBC) in New York City.
NCCAT’s established operations at SEMC and NYSBC benefit from the vibrant environment and expertise of
existing highly trained staff. NCCAT occupies custom-built space that provides optimal, environmentally stable
conditions. The primary instrumentation consists of 4 dedicated Titan Krios TEMs, each equipped with direct
detectors and energy filters; 1 (soon to be 3) dedicated Glacios TEMs, each equipped with direct detectors,
and 3 side entry screening microscopes (1 of which is dedicated to NCCAT) equipped with CMOS cameras.
These are augmented by all ancillary equipment needed for the cryoEM workflow, including several classes of
vitrification and sample preparation equipment. NCCAT provides on-site, remote-access, and mail-in data
collection services with fair and equal access to a nationwide user base, and we guide and assist users with all
aspects of cryoEM, including sample preparation, data collection, data processing, data analysis, and structure
refinement. By providing users with access to streamlined workflows and resources, NCCAT allows
researchers to collect high-quality data quickly and efficiently, which will lead to faster progress in structural
biology research. NCCAT’s training program encompasses a full range of expectations, from the basics
required to ensure that users produce valid structures, through more detailed training for users seeking
independence, to those expected to run cryoEM research laboratories. A well-established grid preparation and
screening service program supports new practitioners of cryoEM methods and/or laboratories that lack local
facilities and resources to optimize sample and grid preparation conditions and, when possible, obtain
preliminary cryoEM processed data. We propose to be transformative by setting the standard for access and
training to cryoEM technology. By facilitating the shift from the current model of isolated and expensive
facilities to a unified and more efficient Center, we will enable science of the highest quality and value and
therefore provide essential foundational knowledge needed to develop new therapies, diagnostics, and clinical
practices to better human health.

Public health relevance
Project Narrative CryoEM has unique capabilities to study biological systems at atomic resolution that are not accessible to other structural methods. NCCAT provides a unified facility to lower the barriers to nationwide access to state-of-the- art equipment and technical support, to enable the production and analysis of high-resolution cryoEM structures. NCCAT will lead an educational program to engage and train the scientific community from neighboring fields to maximize the benefit for non-experts and expand the reach of the field while boosting the scientific output.